HIGH THROUGHPUT SCREENING ASSAY DEVELOPMENT FOR PHARMACOPERONES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The specific aim is to produce and validate screens for identification of pharmacoperone drugs from molecular libraries which exert their actions by a newly appreciated therapeutic approach[unreadable]namely, control of post-translational protein folding and, as a consequence, cellular trafficking and rescue of mutated proteins. G protein coupled receptors (GPCRs) are frequently targeted in library screening, yet this approach generally relies on screens that identify agonists or antagonists and would have missed many of the drugs that will be identified in the proposed screens. Our approach identifies drugs with a significant degree of novelty in therapeutic approach, relying on cellular mechanisms that are not currently represented in the Molecular Libraries assay pipeline;this offers an untapped opportunity for use of the HTS approach.